Unraveling the Cellular Dynamics of the Cranial Base Synchondroses Throughout Postnatal Craniofacial Development

The cranial base growth center synchondroses are essential for regulating bidirectional postnatal craniofacial
growth and skeletal patterning of the midface by forming the structural foundation for the upper nasal airway and
masticatory complex. Similar to the long bone growth plate, chondrocytes in the synchondroses are organized
into resting, proliferating and hypertrophic zones that ossify during skeletal maturation. Importantly, organization
and activation of proliferating chondrocytes is required to promote cranial base growth. Fibroblast growth factor
receptor 3 (Fgfr3) is expressed in chondrocytes in the synchondroses and Fgfr3 gain-of-function mutations cause
achondroplasia associated with premature fusion of the synchondroses and midfacial hypoplasia in humans and
mice. Current treatments for midfacial hypoplasia are limited to craniofacial and orthognathic reconstructive
surgeries in patients. Despite these clinically meaningful findings, it is unknown how Fgfr3+ chondrocytes behave
throughout postnatal synchondrosis growth. Therefore, the overall goal of this proposal is to identify mechanisms
by which Fgfr3+ proliferating chondrocytes orchestrate postnatal synchondrosis growth and maturation. My
preliminary data suggests that conditional deletion of the causative gene for cleidocranial dysplasia, runt-related
transcription factor 2 (Runx2), in Fgfr3+ chondrocytes in mice causes premature fusion of the synchondroses,
accelerated chondrocyte hypertrophy and decreased osteoblast formation. Although Runx2’s role as a central
regulator of osteoblast differentiation and skeletal formation has been established in long bones, its function in
synchondrosis development remains unknown. By combining our current knowledge of Fgfr3-related cranial
base malformations with my extensive preliminary data, I hypothesize that Fgfr3-expressing chondrocytes
maintain the bidirectional orientation and growth potential of the postnatal cranial base synchondroses
through a mechanism dependent on Runx2 activation.
Two aims are proposed to address the central hypothesis. 1. Assess the clonal dynamics and cellular
heterogeneity of Fgfr3+ chondrocytes in the synchondroses. 2. Define the role of Runx2 on Fgfr3+ chondrocyte
organization in the synchondroses. This project seeks to provide novel mechanistic insight into postnatal
synchondrosis growth and maturation, thereby advancing the current scientific state of cranial base biology.
Furthermore, these investigations aim to unravel an innovative mechanism placing Runx2 as a central regulator
of postnatal synchondrosis development. Notably, this project intends to catalyze future studies into
therapeutically targetable Fgfr3-related pathways mutated in patients with malformed synchondroses.

Public health relevance
Midfacial hypoplasia is a devastating condition caused by structural defects of the cranial base, resulting in difficulties breathing, chewing and often necessitating surgical correction. While it is understood that the cranial base promotes craniofacial growth, and that cartilage cells (chondrocytes) are required for its development, the molecular mechanisms that regulate these processes are unknown. The objective of this proposal is to define mechanisms by which cranial base chondrocytes function to promote growth of the midface in order to identify future therapeutic targets for the treatment of cranial base malformations.